Exploring the Impact of Altered Backbone Composition on Protein Folding and Function

PROJECT SUMMARY
Proteins drive essential functions of life as well as aberrant functions in disease, making the development
artificial molecules that mimic proteins a significant challenge in biomedical research. The problem of protein
mimicry is rooted in the hierarchy that defines protein structure, where covalent connectivity gives rise to local
folding motifs, unimolecular arrangements of such motifs, and multi-chain assemblies. The construction of
sequence-specific oligomers with artificial backbones and defined folding propensities is a powerful approach
to peptide and protein mimetics. Most precedent with such scaffolds has focused on isolated secondary
structure. Creating more complex tertiary folding patterns presents a formidable challenge, as it requires the
design of both backbone connectivity and side-chain sequence that will result in multiple biomimetic
secondary structures that pack in a defined way in a single chain. Addressing this challenge has the potential
to advance artificial protein-like chains toward the functional versatility of biomacromolecules.
A unifying theme underlying research in the PI’s laboratory is the design, synthesis, and application of
molecules that are inspired by proteins but expand beyond natural constraints of covalent connectivity. A
major goal in this work, supported in prior awards from NIGMS, has been the development of strategies for
producing protein tertiary structure mimetics from artificial bio-inspired backbones. The central hypothesis
guiding this effort is that any protein can be treated as a chemical entity with two orthogonal sequences: one
of side-chain functional groups and a second of backbone units that display those functional groups.
Systematic engineering of backbone composition in a prototype sequence from nature can yield a
heterogeneous-backbone analogue with similar fold and function. In work to date, design rules have been
conceived for the construction of such agents, the impacts of altered composition on folding examined, and
the functional potential of these molecules explored. The present application seeks to advance this program
through continued effort across four complementary research areas.
From a practical standpoint, artificial backbone composition can impart useful properties, such as
enhanced biostability, and tune biological activity. In fundamental terms, changing backbone characteristics
in ways not possible with traditional mutagenesis can further understanding of natural biomacromolecules.
An important aspect of the concept underlying the research is that it addresses the problem of tertiary
structure mimicry by an approach that is generalizable, as natural sequences serve as the starting point for
design of their own mimics. Further, while the molecules are synthetic, the design principles are applicable in
the context of new emerging approaches to biological production of protein-like artificial chains.

Public health relevance
The proposed project seeks to explore the development of synthetic molecules that mimic complex protein structures and functions. The public health relevance of the work stems from the potential applications of these molecules as bioactive agents as well as their utility in shedding light on fundamental issues related to natural protein behavior.